TREATMENT OF GAUCHER DISEASE USING GLUCOCEREBROSIDASE INFUSION

The uptake of glucocerebrosiadase is dramatically improved by exposing mannose residues in the oligosaccharide side chain of the glycoprotein. This strategy enables enzyme infusions as a therapeutic tool. The GCRC supported clinical studies are aimed at determining the lowest doses of enzyme needed to be effective treatment.